Patient Readiness for Improvement through Motivation, Engagement, and Decision-making for PTSD (PRIMED-PTSD)

Background: Over 1 million Veterans have PTSD and most (80% or more) do not receive first-line treatments,
evidence-based psychotherapies, despite significant VA investment to increase access to these treatments.
Clinicians often struggle to engage Veterans in evidence-based psychotherapies because they can be
emotionally challenging treatments. Engagement could be catalyzed by mental health providers integrated into
primary care (i.e., VA’s Primary Care-Mental Health Integration, or PC-MHI) to maximize the reach of
engagement efforts beyond specialty PTSD settings. Shared decision making, a process by which the patient
and provider discuss treatment options, weigh benefits and risks, and select a treatment that meets the
patient’s needs, addresses known patient and provider barriers to evidence-based psychotherapies, including
knowledge, self-efficacy, and trust. However, no study has examined shared decision making for PTSD in
primary care. The proposal will address this knowledge gap by developing and refining a shared decision
making intervention for PTSD, Patient Readiness for Improvement through Motivation, Engagement, and
Decision-making (PRIMED), using input from Veterans with diverse perspectives, PC-MHI providers, and VA
operational partners to optimize integration of shared decision making into clinical care. We will collect
acceptability and feasibility data to support an application for a future effectiveness-implementation trial.
Significance/Impact: Dr. Chen’s proposed research addresses three HSR&D and VA priorities: 1) increase
engagement and retention of Veterans in evidence-based PTSD treatments, 2) advance health services
research methods, specifically implementation science and user-centered design, which focuses on thorough
integration of Veteran and frontline provider input, and 3) support suicide prevention efforts through effective
treatment of PTSD, a major risk factor for suicide.
Innovation: The proposed project will promote significant change in current VA clinical practice. PC-MHI
providers typically refer out patients with PTSD and defer discussions about treatment options to specialty
providers. This proposal will help PC-MHI providers use a formal engagement strategy, shared decision
making, to improve patients’ knowledge of first-line PTSD treatments and to build motivation for care.
Specific Aims: 1) Refine PRIMED using user-centered design methods and diverse Veterans’ perspectives,
2) Beta test PRIMED in one rural and one urban PC-MHI clinic to optimize integration into clinical workflow and
achieve satisfactory acceptability and feasibility across a range of settings, 3) Conduct a small, randomized
pilot trial (N=40) of PRIMED vs. usual care in two VA PC-MHI clinics to assess the feasibility of study
procedures, which will inform a future larger trial.
Methodology: In Aim 1, Dr. Chen will conduct qualitative interviews using user-centered design methods with
25 VA PC-MHI patients with PTSD, oversampling women veterans and racial/ethnic minority veterans, to refine
the PRIMED intervention protocol. In Aim 2, Dr. Chen will use rapid, iterative beta-testing with approximately
20 patients to optimize the acceptability and feasibility of delivering PRIMED in the clinical setting and its
integration into clinical workflow across varied settings (small rural clinics and large urban clinics). In Aim 3, Dr.
Chen will conduct a pilot randomized feasibility trial (N=40) to assess the feasibility of recruiting and
randomizing Veterans and measuring treatment engagement and clinical outcomes.
Next Steps/Implementation: The research and training activities will prepare the nominee to conduct a multi-
site, hybrid type 1 effectiveness-implementation trial to test the effectiveness of PRIMED for increasing receipt
of first-line PTSD treatments and to begin to assess implementation barriers and facilitators. Future work to
move this research into practice would involve collaborating with operational partners to improve VA SAIL
performance measures in mental health, which are weighted to encourage evidence-based psychotherapies.

Public health relevance
PTSD is one of the most common mental health conditions affecting Veterans and is associated with significant burden. Highly effective treatments exist for PTSD, evidence-based psychotherapies, but very few Veterans receive them. Although VA has trained over 8,500 providers in evidence-based psychotherapies for PTSD over the past 10 years, only 6% of the 650,000 VHA patients with PTSD receive an evidence-based psychotherapy. It is critical that we connect Veterans with our most effective PTSD treatments and that we do so in a way that is Veteran-centered. Shared decision making is a patient-centered approach to choosing healthcare treatment options. It has been shown to increase patients’ motivation for treatment and ability to stay in treatment long enough to get benefit. It has also been shown to help providers align their practice with evidence-based guidelines. This proposal will refine and pilot test a shared decision making intervention for PTSD to be used in VA primary care clinics, where the vast majority of Veterans with PTSD are treated.